Regulatory Mechanisms of Glycoprotein Sialylation

Summary
A major gap in the “bench to bedside” paradigm is the ability to harness the glycome for the development of
novel therapeutics. Although decades of research in glycobiology have established glycomic changes
associated with disease, almost nothing is known about how those changes arise, the functions they play in
disease initiation or progression, or how the glycome is regulated at the compositional level. Based on our
recent discoveries, we propose a transformative new model for glycomic compositional regulation of
secreted glycoproteins that provides a clear path for the development of the first generation of glycan-
modulating therapies for a wide range of diseases. The model is based on the notion that the glycans on
glycoproteins can be remodeled after release from the originating cell, and if correct, our findings will rewrite
the glycobiology dogma that glycomic changes are dependent upon the slow process of protein turnover and
de novo synthesis to one where change is highly dynamic, rapid, and specific to the immunologic
environment. The proposal centers on the molecular action, regulation, and necessary microenvironment for
the sialyl transferase ST6Gal1 to add α2,6-linked sialic acids onto IgG glycans. Our proposal focuses upon
the B cell-secreted antibody IgG because alterations in sialylation alters Fc domain conformation and FcγR
binding such that anti-inflammatory signaling is enhanced. We have discovered that the vascular
endothelium and the FcRn-mediated recycling pathway is the dominant system through which IgG is
sialylated, leading to two proposed specific aims. In Aim 1, we will define the biochemical and cellular
mechanisms of FcRn-dependent IgG sialylation in the endothelium. In Aim 2, we will interrogate the
regulatory features underlying changes in IgG sialylation during inflammatory responses. The overall goal is
to develop a comprehensive understanding of the mechanisms underlying the regulation of IgG sialylation
which will provide a lasting and profound impact on the field and human health. It is known that the
suppressive activity of exogenous intravenous Ig therapy is enhanced by IgG sialylation. Through an
understanding and targeting of the fundamental regulatory tenets of this novel pathway, we could finally
unlock the potential to modulate the sialylation of endogenous IgG within patients with inflammatory disease.

Public health relevance
Project Narrative This research program is based on the premise that dynamic and targeted regulation of protein glycosylation serves to modulate glycoprotein form and function to meet the immediate biological need. More specifically, we are focused on endothelial cells that line the vasculature which we have discovered modulate antibody activity, ranging from anti- to pro-inflammatory effector function, through a pathway of recycling and remodeling of conserve glycans on IgG. Our long-term goal is to dissect the mechanism by which this occurs such that novel therapies targeting antibody glycosylation can be developed for inflammatory and autoimmune diseases.